Microtubule dynamics and error correction

Project Summary
This project requests funding to upgrade equipment to clone and analyze CRISPR/Cas9
transgenic recombinant cells. These cells are required to address the Specific Aims in
NIH grant R01GM145567. The broad goal of this project is to understand the
mechanistic contribution of force generation by kinesin-related motors and dynamic
microtubules to chromosome segregation. To accomplish these goals we engineer
CRISPR cells with fluorescently tagged kinesin motors that can be rapidly relocated to
diverse regions of the cell. We have found that functional analysis of proteins in these
cells is much more physiologically relevant than the more commonly used transfection
and expression methods. This is in part because the proteins are at the appropriate
level in the cell and in part because there is no contaminating activity from endogenous
protein because the modifications for visualization and experimental manipulation are
performed on the endogenous gene. One disadvantage is that the physiologically
relevant levels of protein is challenging to image in cells. Our isolation and analysis of
these cells is performed microscopically and critically dependent on our imaging
equipment. To isolate and functionally evaluate these cells we use a custom-modified
high resolution, light sensitive GEHealthcare microscopy system. Unfortunately, the
company that previously covered its service contract (GEHealthcare/Cytiva) no longer
exists as a microscope company. Thus, there are no parts available to cover instrument
failures. As of 9/12/22 the instrument controller has failed leaving us without the key
instrument underscoring our productivity for live cell imaging. We have devised a means
to cannibalize the working parts of our system and combine it with a minimal version of
the Nikon CREST X-Light V3 spinning disk confocal. This system will have two
advantages: 1) it will reinstate our imaging capabilities and, accordingly, our scientific
productivity; and 2) it will allow us to image both flat cultured cells and embryonic
zebrafish. This will provide us with both additional capability to investigate the
contribution of poorly expressed kinesins (such as Kif9 and Kif25) to organismal
development, per our approved change of scope addition of Danio rerio, and restore our
ability to isolate and evaluate CRISPR-engineered cell lines.

Public health relevance
Project Narrative Using microscopic tools, we generate and experimentally analyze CRISPR/Cas9 cells that express novel kinesins and regulators of microtubule dynamics at endogenous levels as part of project R01GM145567. Danaher (a conglomerate that recently purchased GEHealthcare's Life Sciences division) made the decision in 2020 it would no longer market or support the unique GEHealthcare/Deltavision microscopes that we use to isolate and analyze our cell lines. While, as of 9/12/22 our key microscope has failed severely limiting our productivity, we have determined that a number of the parts from our existing instrument can be used in conjunction with a cost-effective minimal version of the Nikon CREST X-Light V3 spinning disk confocal to continue our studies.